Mechanisms of regulatory T-cell mediated endothelial repair following viral pneumonia in aged hosts

PROJECT SUMMARY/ABSTRACT
The broad objectives of this K08 proposal are two-fold: 1) to facilitate development of the necessary skills that
will allow the candidate to achieve her long-term goal of becoming a successful physician-scientist focusing on
determinants of recovery from viral pneumonia in aged hosts, and 2) to investigate the mechanisms that direct
the Tregs to orchestrate resolution of severe lung injury throughout the lifespan. The candidate and her mentors
have designed a detailed training plan tailored to the candidate's specific needs and goals. The plan includes a
rigorous research component that will afford the PI new knowledge and research skills to better examine the
links between a critical immune cell population and the endothelium during recovery from viral pneumonia. The
proposal concerns viral pneumonia, specifically influenza-induced lung injury, its clinical counterpart the acute
respiratory distress syndrome (ARDS) and how they both disproportionately affect the elderly population. Despite
decades of dedicated research, there are only a few anti-viral therapies with limited efficacy to manage severe
viral pneumonia. Tregs have been shown to decrease inflammation and promote tissue repair in diverse murine
models of lung injury. Tregs also increase in the lungs of patients with ARDS, suggesting that they may play a
role in the human adaptive immune response to lung injury. However, the specific mechanisms that cause Tregs
to execute their pro-repair program following lung injury remain unknown. Our preliminary data shows that the
youthful reparative Treg cell program following influenza-induced lung injury is dominated by biologic processes
linked to the development and repair of blood capillaries. This reparative program is lost in aged hosts in a cell-
autonomous manner. Thus, we hypothesize that aging results in Treg cell-specific downregulation of important
pro-angiogenic factors expression such as VEGFA, leading to impaired alveolar endothelial repair and recovery
from viral pneumonia. The long-term goal of the proposal is to identify novel small molecule- and cell-based
therapeutics to control inflammation and promote tissue repair in our increasingly older population. To test this
hypothesis, we propose the following Specific Aims: 1) determine whether age-related alterations in the pro-
endothelial repair function of Tregs results from cell-autonomous or microenvironmentally-driven changes, 2)
determine whether Treg cell-generated VEFGA is necessary and sufficient to restore the pro-endothelial repair
function present in youth that is lost with aging, and 3) determine whether age-related VEGFA expression in
alveolar Tregs in bronchoalveolar lavage fluid is associated with 30-day mortality in patients with severe viral
pneumonia. We will use standard techniques to assess severity of lung injury, endothelial repair, heterochronic
(age mis-matched) adoptive Treg cell transfer, multiple transgenic murine strains for loss-of-function and gain-
of-function experiments, flow cytometry, fluorescence-activated cell sorting and transcriptional profiling with
RNA-sequencing as the primary methods to support the experimental design of this proposal.

Public health relevance
PROJECT NARRATIVE Influenza A virus (IAV) infection and pneumonia represent the leading infectious causes of death in the United States, and disproportionately affect the elderly. Regulatory T (Treg) cells coordinate the resolution of lung injury, but the mechanisms underpinning the loss of pro-endothelial repair function in Treg cells from aged hosts remains unknown. We aim to uncover the transcriptional and functional changes that determine the gain and loss of pro-endothelial cell repair function in Treg cells following viral pneumonia throughout the lifespan.